PURIFICATION OF DES-CARBOXY VITAMIN K DEPENDENT PROTEIN FROM WARFARINIZED BLOOD

Validation of assays designed to measure abnormal warfarinized proteins in plasma. Purification of warfarinized proteins from the blood of volunteers on Coumadin.